Querying the Interactome of Alpha-Synuclein During Pathological Processes

PROJECT SUMMARY/ABSTRACT
Alpha-Synuclein (aSyn) is an intracellular neuronal protein which is implicated in a variety of neurodegenerative
diseases including Lewy body (LB) dementias (consisting of Dementia with Lewy Bodies and Parkinson’s
disease dementia), Parkinson’s disease, and Multiple Systems Atrophy. Endogenous healthy aSyn is involved
in synaptic function; in pathogenic states, aSyn is believed to misfold, accumulate into oligomers and fibrils, and
ultimately become part of large insoluble aggregates such as Lewy bodies and Lewy neurites. It is still unknown
why aSyn aggregates begin to form. It is also unclear whether pathogenic aSyn exists in primarily monomeric or
multimeric form, with the field currently believing that oligomeric aSyn may be toxic. Thus, there is great need to
better understand cellular mechanisms involved in aSyn aggregation in disease pathology. The proposed study
focuses on understanding the protein interactors of alpha-Synuclein during early aggregate formation
and propagation. Protein-protein interactions and related mechanisms identified in this study have
potential to facilitate biomarker development for early LB dementia diagnosis and/or promote new
candidates for successful disease-modifying therapies. I will employ an in vitro proximity-dependent biotin
identification (BioID) system to characterize the aggregate interactome of aSyn. This model is an unbiased
antibody-free method for tagging proteins of interest; a mutant R118G BirA* biotin ligase enzyme will be fused
to aSyn. Upon exogenous addition of biotin to in vitro assays, proteins within a 10nm radius will be biotinylated.
Proteomic analysis of enriched biotinylated peptides will identify potential interactors. Aim 1 will characterize
intracellular changes in the aSyn interactome in seeded and non-seeded states. Aim 2 will uncover proteins
involved in aSyn secretion and propagation in seeded and non-seeded states. Validation of potential interactors
will be performed using in vitro models such as split VenusYFP, split luciferase, siRNA knockdown, and co-
immunoprecipitation assays. Analysis of post-mortem LB dementia patient tissue will investigate the presence
of a protein target in late-stage LBs – suggesting true involvement of a protein target in pathological processes.
Novelty of the proposed project comes from (1) the application of split BirA* fragments fused to aSyn to identify
interactors of multimeric aSyn and (2) the use of LB dementia patient-derived pathogenic seeds to increase
physiological relevance of this study. The proposed experiments will be carried out at Mayo Clinic, a research
institution with state-of-the-art lab facilities and expert scientists leading advancements in neurodegeneration.
With these resources, the long-term objective of this project is to reduce the burden of synucleinopathies
for patients and their caregivers.

Public health relevance
PROJECT NARRATIVE Lewy body dementias (LBD) represent one of the most common forms of progressive dementia in adults, with symptoms that often begin decades before a clinical diagnosis is made. The goal of this project is to identify proteins, and associated cellular mechanisms, which may contribute to early stages of alpha-Synuclein pathology in Lewy body dementias. Findings from this study have potential to facilitate biomarker development for early LBD diagnosis and/or promote new candidates for successful disease-preventing therapies.